Biogenic amines, malaria and manipulation of mosquito physiology and behavior.

Project Summary/Abstract
Severe malaria induces changes in circulating blood levels of the biogenic amines histamine and serotonin
(5-hydroxytryptamine, 5-HT) and these changes are associated with human disease pathology. Histamine and
5-HT are also important neuromodulators in insects, including mosquitoes. Our overarching hypothesis is
that histamine and 5-HT, ingested in blood by feeding mosquitoes, signal through anopheline biogenic amine
receptors and alter endogenous biogenic amine levels, life history traits, behavior and mosquito infection
success to amplify malaria parasite transmission. These studies are innovative in that they connect novel
mosquito biology to clinical observations in malaria, they focus on mosquito ingestion of biogenic amines at
physiological levels detected in blood and they will define previously unexplored anopheline gut-brain axes for
histaminergic and serotonergic signaling. We will address our overarching hypothesis with three Specific Aims.
In Aim 1, we will define and model the scope of effects of ingested histamine and 5-HT, alone and in
combination at concentrations that reflect malaria-associated and healthy blood levels, on An. stephensi
infection success with Plasmodium falciparum and with the mouse parasite Plasmodium yoelii yoelii 17XNL.
We will also examine the effects of these treatments on the tendency to take a second bloodmeal,
thermotolerance, fecundity, clutch size and lifespan. In Aim 2, we will use antennal and retinal recordings and
behavioral bioassays to define the effects of ingested histamine and 5-HT, alone and in combination, on visual
and olfactory physiology in An. stephensi. In Aim 3, we will quantify endogenous histamine and 5-HT in An.
stephensi and map associated histaminergic and serotonergic gut-to-brain signaling networks. We will also
identify and model effects of ingested biogenic amines on levels of endogenous biogenic amines and use
histamine and 5-HT receptor antagonists to interrupt signaling control of malaria parasite infection, tendency to
take a second bloodmeal and reproduction in An. stephensi. With completion of these studies, we will establish
that biogenic amine concentrations associated with severe malaria and ingested by feeding mosquitoes can
alter mosquito physiology and biology in patterns that would be predicted to favor parasite transmission. Such
knowledge can be used in the future to connect transmission control to clinical interventions (e.g., to reduce
elevated histamine and reverse declines in 5-HT to mitigate human malarial disease) and for future
development of novel lures to manipulate biogenic amine signaling in vector mosquitoes.

Public health relevance
Project Narrative Nearly 60% of the global population is at risk for malaria, a disease caused by mosquito-borne parasites that circulate in human blood. These studies focus on two molecules, histamine and serotonin, which circulate in blood, are associated with dangerous symptoms of malaria, and are ingested by mosquitoes when they feed on blood. We hypothesize that ingested histamine and serotonin alter mosquito physiology to favor malaria parasite transmission, suggesting that future interventions to block these small molecules in humans would reduce both disease and mosquito transmission.